Peer PrEP referral + HIV self-test for PrEP initiation among young Kenyan women

ABSTRACT
The uptake of HIV pre-exposure prophylaxis (PrEP), a highly effective prevention intervention, remains low
among adolescent girls and young women (AGYW, ≥16-24 years) in Africa, a priority population for HIV
prevention interventions. Compared to other populations, African AGYW are at increased risk of HIV infection;
in Kenya, AGYW account for 33% of the total of new HIV infections yet comprise only 10% of the population.
Barriers to PrEP initiation for AGYW are multi-faceted and include institutional (e.g., stigma associated with use)
and intra-personal (e.g., lack of PrEP knowledge or self-efficacy) barriers. Innovative PrEP delivery models that
can help overcome these barriers are needed. The opinion of peers often influences the behaviors and
preferences of AGYW; the majority of AGYW who have initiated PrEP in Africa to date have done so because of
informal peer referral. HIV self-testing (HIVST) is a new technology that has the potential to enhance peer PrEP
referral. Much of the emphasis on HIVST to date has been on identifying new individuals living with HIV and
facilitating linkage to treatment interventions, but most individuals who self-test will test negative and may be
interested in facilitated linkage to prevention interventions. We hypothesize that a formalized peer PrEP referral
+ HIVST delivery model (developed during the K99 phase of the R00 parent award) can amplify PrEP initiation
among Kenyan AGYW at HIV risk. In this supplement application, the research aims of the R00 parent award
have remained unchanged. The first aim, which has been completed, pilot tested and refined an intervention
where Kenyan AGYW using PrEP (i.e., peer providers) referred their peers (i.e., peer clients) to PrEP following
a formalized training on peer referral paired with distribution of HIVST kits. The pilot found that this intervention
had high feasibility and acceptability. The second aim, which is ongoing, is measuring the effect of a refined
version of this intervention (based on Aim 1 findings) on PrEP initiation among AGYW in a 2-arm hybrid
effectiveness-implementation cluster-randomized controlled trial (cRCT). The control arm of this cRCT is informal
word-of-month peer PrEP referral and the trial is measuring both effectiveness (e.g., PrEP adherence) and
implementation (e.g., adoption, fidelity, cost) outcomes. To date (from May 3 to September 15, 2023), 35 peer
providers (44% of the targeted 80) have enrolled in the cRCT. However, unexpected implementation challenges
– including approval delays, participant recruitment challenges, national civil unrest, and supply chain challenges
– have made cRCT recruitment and enrollment much slower than expected. Thus, we are requesting an
administrative supplement to ensure we can reach our final trial endpoints and generate high-quality evidence
that indicates whether the proposed intervention increases PrEP initiation among an important population at HIV
risk (i.e., AGYW). The findings from this trial will inform national and international PrEP implementation guidelines
as well as an NIH R01 proposal for a community-randomized controlled trial, which can help launch the
independent research career of Dr. Ortblad, the Principal Investigator and an early-stage investigator.

Public health relevance
PROJECT NARRATIVE Few adolescent girls and young women (AGYW, ≥16 to 24 years) at risk of HIV acquisition are initiating pre- exposure prophylaxis (PrEP) for HIV prevention in Kenya. Thus, in the R00 parent award of this supplement application, we proposed refining and testing a new model to increase PrEP initiation among AGYW at HIV risk that has never been explored: formalized peer PrEP referral + HIV self-test delivery. Unexpected implementation challenges (e.g., approval delays, participant recruitment challenges), however, have had cost implications for this award so we are requesting additional resources to complete the proposed R00 parent award research on time and generate high-quality evidence on how to engage an important population in PrEP services.